Subtractive assembly approaches for inferring disease-associated microbial genes and pathways from microbiome sequencing data

Summary
Successful translational applications of microbiome research rely on computational tools
that can effectively detect microbial markers that are associated with diseases, and
provide explanations to the associations. We propose to develop subtractive assembly
approaches to microbiome sequencing data analysis, aiming to identity microbial genes
and pathways that are associated with diseases. The advantages of using subtractive
assembly approaches include: 1) they significantly reduce the complexity of the fragment
assembly problem by focusing only on the potential difference (genes and genomes) at
the initial (instead of the final) stage of the comparative analysis pipeline, and 2) they
improve the assemblies of differential genes, which are important inputs for building
predictive models for disease diagnosis and characterization of treatment efficacy. We
will apply our new tools to analyzing disease-associated microbiomes including those
associated with type II diabetes, liver cancer, inflammatory bowel disease (IBD) and
those known to be related to the efficacy of cancer immunotherapy.

Public health relevance
Narrative Our subtractive assembly approaches will be a timely addition to the computational tools that are central to the interpretation of microbiome-disease association, leading to a better understanding of the impacts of microbial communities on human health and diseases, and the mechanisms behind. Ultimately, these tools will be useful for translational applications of microbiome data for disease diagnosis, treatment responsiveness prediction and disease prevention.